Personalized Deep Learning Models of Rapid Changes in Major Depressive Disorder Symptoms using Passive Sensor Data from Smartphones and Wearable Devices

ABSTRACT
Major depressive disorder (MDD) is highly prevalent and the leading cause of global disease burden.
Associated with over 1,000 different symptom profiles, MDD is highly heterogeneous. The majority of MDD
symptom change occurs across hours. Consequently, there is a need to increasingly focus MDD research on
personalized assessment of these rapid symptom fluctuations. To date, personalized models of MDD have
shown promise, but relied solely on self-report measures. There is thus a critical need to develop personalized
models of MDD that incorporate objective signals. Passively collected information from smartphones and
wearable sensors can continuously and unobtrusively track behavioral and physiological signals related to core
disturbances associated with MDD, including psychomotor retardation, sleep disturbances, social contact,
behavioral activation, heart rate variability, and screen time. Preliminary data suggest that personalized
artificial intelligence (i.e., personally weighted deep learning models) are well suited for creating novel
personalized digital biomarkers of these passive indicators, and that these biomarkers can predict rapid
changes in MDD symptoms. This proposal will investigate the ability to develop personalized deep learning
models of rapid changes in MDD symptoms among a nationally representative sample of 120 treatment
seeking adults with MDD across 90 days using passively collected data from smartphones and wearable
sensors. This proposal aims to test the accuracy of personalized, subtyped, and cohort-based modeling
techniques and uncover personalized digital biomarkers of moment-to-moment changes in MDD symptoms.
The project proposes the following innovations: it will (1) conduct the first passive-sensing study of MDD in a
nationally-representative cohort; (2) utilize deep learning models to aid in the discovery of novel maintenance
factors of MDD symptom changes; and (3) use personalized multimodal assessments of MDD to address the
heterogeneity in MDD. In line with the aims of the NIMH Research Domain Criteria (RDoC), this project will
study MDD symptom changes across multiple units of analysis and integrate multiple systems. This study will
provide a critical step towards uncovering novel personalized maintenance patterns of MDD symptom changes
in daily life. Further, it will allow for scalable personalized treatments to be developed using technology to
deliver behavioral interventions in the moments immediately preceding rapid MDD symptom changes.

Public health relevance
PROJECT NARRATIVE This project aims to utilize personalized artificial intelligence techniques and objective data (collected from smartphones and wearable devices) to create individualized digital biomarkers of rapid changes in major depressive disorder symptoms. This is important because, if we were to uncover personalized patterns between objectively measured physiology and behavioral changes and understand their resulting impact on rapid fluctuations in major depressive disorder symptoms, we would be able to define new, person-specific maintenance patterns that underlie the wide-ranging heterogeneity that is currently seen in patients suffering from major depressive disorder. Moreover, these advancements will provide a crucial step forward towards developing personalized, scalable, technology-based interventions that will be able to be delivered immediately (and, ideally, before rapid symptom changes) among those persons with major depressive disorder.